Epigenetic regulation of the Meibomian gland in homeostasis and aging

SUMMARY
The overall goal of this proposal is to delineate epigenetic mechanisms that control Meibomian gland
homeostasis and are dysregulated in aging. The Meibomian gland’s key function is to secrete a lipid-rich film
that coats the ocular surface and prevents tear film evaporation. Aged Meibomian glands show reduced size
and decreased proliferation of basal progenitor cells. These phenotypes are thought to contribute to
Meibomian gland dysfunction in aging, including development of Evaporative Dry Eye Disease (EDED) which
is common in aged patients, can seriously impair vision and currently has no effective treatment. Histone
deacetylases (HDACs) are druggable targets with therapeutic potential and play key roles in controlling
progenitor cell activity and maintenance in other epithelia. HDACs function by modifying chromatin and by
controlling the activities of key transcription factors. Our published data show that inducible Hdac1 and Hdac2
deletion in adult Meibomian gland basal cells causes decreased proliferation and Meibomian gland loss. The
transcription factor GLI2, a key component of the Hedgehog pathway, is hyper-acetylated in Hdac1/2 mutant
Meibomian glands, a modification that is known to reduce GLI2’s transcriptional activity and association with
active chromatin. Deletion of the Hedgehog co-receptor Smo causes decreased basal proliferation and
Meibomian gland hypoplasia, partially mimicking Hdac1/2 loss, while epithelial deletion of the Hedgehog
inhibitory co-receptor Ptch1 or forced expression of activated GLI2 in Meibomian gland basal cells results in
acinar basal cell expansion, identifying Hedgehog signaling and GLI2 as key regulators of Meibomian gland
proliferation. Comparative analysis of single nuclear RNA-seq data from the eyelid tarsal plates of young and
old mice showed that Hedgehog signaling is decreased in aged compared with young Meibomian glands. This
decline is associated with increased acetylation of GLI2 and histone H3, suggesting that HDAC1/2 activity is
decreased in aged Meibomian glands. By contrast, Hdac3 deletion increases basal progenitor cell proliferation
and GLI2 expression but not its acetylation levels, like the effects of elevated Hedgehog signaling. Based on
these data we hypothesize that HDAC1/2 and HDAC3 play distinct and key roles in adult Meibomian gland
progenitor cells in part by differentially modifying the expression and activity of Hedgehog pathway
components and target genes, and that decreased HDAC1/2 activity contributes to aging phenotypes. To test
this hypothesis and delineate additional mechanisms in an unbiased fashion, we will use genetic and single-
cell genomics approaches to identify the direct targets and transcriptional co-regulators of HDAC1/2 and
HDAC3 in Meibomian gland progenitor cells and determine the extent of overlap in HDAC1/2-regulated genes
with those dysregulated in aging. These experiments have potential to reveal novel therapeutic strategies to
enhance progenitor cell activity in aged Meibomian glands.

Public health relevance
NARRATIVE Meibomian glands prevent tear film evaporation by secreting an oily coating over the surface of the eye, and their decreased proliferation and shrinkage in aging is associated with evaporative dry eye disease that has no effective treatment. The overall goal of this grant is to uncover epigenetic mechanisms that maintain the Meibomian gland in homeostasis and are altered in aging; these studies have the potential to reveal new therapeutic targets for aging-associated Meibomian gland dysfunction.